Rapid detection of Hepatitis C virus using CRISPR/Cas

PROJECT ABSTRACT/SUMMARY
In 2017, WHO estimated 71 million people had chronic Hepatitis C Virus (HCV) but 81% of the living patients
were unaware of their infection status. In 2016 alone, an estimated 399,000 HCV-related deaths were reported by WHO.
CDC estimates that between 2013-2016, around 2.1 million people were infected with HCV within the US and only a
fraction of them were diagnosed properly. A rapid and reliable detection of an early-stage HCV would allow quicker
intervention and can significantly reduce the risk of death and infection rate. An innovative self-testing diagnostic platform
for early detection of HCV RNA using engineered type V and VI CRISPR/Cas systems can be created. Type V and VI
CRISPR/Cas systems when bound with their specific target nucleic acid sequence, activate a secondary collateral nuclease
activity that can rapidly cleave single-stranded nucleic acids in a non-specific multiple turnover manner. By detecting the
collateral activity of CRISPR/Cas systems using a FRET-based reporter, up to 10 nM of target sequence has been
fluorescently detected by Doudna and Zhang labs. By pre-amplifying a target using a reverse transcriptase and/or isothermal
DNA amplification, single molecule detection of RNA or DNA has been achieved with concentrations as low as 2 aM. In
preliminary unpublished work, engineered CRISPR RNA (crRNA) for CRISPR/Cas12a were discovered to amplify this
further and achieved up to > 400,000-fold improved sensitivity with the limit of detection of 25 fM of PCA3 dsDNA in 6
hours, 700 fM of HIV ssDNA in 30 minutes, and 290 fM HCV ssDNA in 30 minutes without requiring target pre-
amplification. Additional modifications on the CRISPR RNA improved the specificity of detection discriminating single
point mutants.
Based on the preliminary data, there are following specific goals. 1) To enhance sensitivity and specificity of
CRISPR/Cas systems by applying novel engineering rules to different orthologs of CRISPR/Cas12a, CRISPR/Cas13a, and
CRISPR/Cas14a systems that can identify known viral RNA copies with a sensitivity of 100 copies of RNA in 1 mL of
blood. 2) To develop a paper-based device for colorimetric detection of a HCV target by naked eye at 100 target copies/mL
concentration. 3) To perform a pilot study with the optimized device for validating HCV detection in clinical blood samples
from healthy, high-risk, infected and treated patients with 95% accuracy. This integrated approach will have all the
components as defined by the ASSURED (Affordable, Sensitive, Specific, User-friendly, Rapid and robust, Equipment-free
and Deliverable to end-users) criteria by WHO. The development of this rapid diagnostic platform would allow quicker
treatment, reduce outbreak and faster response from patients. In future, this approach would enable detection of co-infections
including TB, HPV, and HIV, and HBV that are the major causes of death in HCV-infected populations.

Public health relevance
PROJECT NARRATIVE Rapid detection of HCV at an early stage using a paper-based point-of-care device can save lives of millions of HCV- infected patients by enabling early intervention and treatment options preventing spreading. This project defines a novel approach to detect HCV RNA based on our engineered CRISPR/Cas12a systems coupled with a paper-based lateral flow assay. This approach will follow the ASSURED (Affordable, Sensitive, Specific, User-friendly, Rapid and robust, Equipment-free and Deliverable to end-users) criteria as recommended by the World Health Organization to make it amenable to the resource-constrained settings.